Measuring Exocrine Pancreas Metabolism in Type 1 Diabetes

Project Summary
Type 1 Diabetes (T1D) is a disease indicated by autoimmune-mediated destruction of the pancreatic β-cells in
the islets of Langerhans, which form 2-5% of the pancreas. Although the vast majority of T1D research has
focused on structural and functional changes in the islets, substantial abnormalities in the exocrine pancreas
also occur with this disease. Acinar cells in the exocrine pancreas synthesize, store, and secrete digestive
enzymes into the duodenum. The long-term goal of this research is to understand the role of exocrine pancreas
dysregulation in the pathophysiology of T1D. This proposal specifically will define changes in central carbon and
lipid metabolism in the exocrine pancreas in T1D. I hypothesize that the T1D exocrine pancreas experiences
increased TCA cycle turnover and de novo lipogenesis (DNL). I will test this hypothesis through two specific
aims. Aim 1 will quantify changes in exocrine pancreatic central carbon metabolism in a transgenic mouse model
of T1D. Aim 2 will determine rates of lipid turnover in the exocrine pancreas. The experiments outlined in Aims
1 and 2 utilize a novel pancreas perfusion method to examine exocrine pancreas metabolism. In aim 1 this is
combined with nuclear magnetic resonance (NMR) spectroscopy using hyperpolarized substrates as well as gas
chromatography-mass spectrometry (GC-MS) to establish the significance of TCA cycle and glycolytic flux in the
exocrine pancreas in T1D pathogenesis. Aim 2 utilizes ex vivo, in vivo, and commercially available assays to
investigate flux through lipid metabolic pathways and lipid storage. This research plan addresses the unmet
biomedical need to understand acinar cell central carbon and lipid metabolism, thus provides critical
insight on mechanisms that drive exocrine dysfunction in T1D. The knowledge gained through this work
will serve as a foundation for understanding how exocrine pancreas dysregulation may affect T1D development
and subsequent β-cell dysfunction.
The fellowship training plan outlines three goals to accomplish my ultimate career goal of becoming an
independent investigator at a tier 1 research institution: i) increase technical expertise ii) improving scientific
communication and iii) engaging in mentorship. This proposal encompasses technical training in pancreas
physiology, stable isotope tracing, NMR spectroscopy, GC-MS, and metabolomics analysis. The Merritt research
group, the Advanced Magnetic Resonance and Spectroscopy (AMRIS) facility, and the Diabetes Institute at the
University of Florida provide an exceptional environment in which to acquire these skills. Furthermore, the Merritt
laboratory supports the improvement of my scientific communication and mentoring abilities. Ultimately, this
training environment is ideal to engage in career development and complete the proposed research.

Public health relevance
Project Narrative Type 1 Diabetes (T1D) is a metabolic disease that has recently been characterized as a disease of the whole pancreas, not just of insulin-producing β-cells. The goal of this proposal is to measure changes in energy metabolism in the exocrine pancreas within the context of T1D. The information gained from this work will provide unique insight into T1D pathophysiology and determine metabolic mechanisms underlying exocrine pancreas anomalies in T1D.